Uncoupling Age- Versus Cognitive-Related Cellular Senescence in Alzheimer's Disease

PROJECT SUMMARY/ABSTRACT
Alzheimer's disease (AD) is a leading cause of disability and death in the US and a major global public health
problem. Time is running short if we wish to avert a global public health disaster with untold suffering,
disruption of families, and severe challenges to health care systems and economies. Effectual solutions will
come only from innovative research. While aging is the biggest risk factor for developing AD, it is unclear to
what extent normal aging is distinct from AD and which age-related factors drive disease. Senescence is a
homeostatic response, which aims to prevent the propagation of these damaged cells while they remain viable
and metabolically active. Senescent-like phenotypes have been described in neurons despite neurons being
post-mitotic cells and these cells may release factors that trigger senescence in surrounding glia. Senescent
glia and senescent-like neurons increase in the brain with age and are thought to contribute to the loss of
function associated with aging and age-related diseases like AD. Our application, entitled “Uncoupling Age-
Versus Cognitive-Related Cellular Senescence in Alzheimer's Disease,” is highly responsive to the objectives
outlined in the RFA-AG-20-025, by leveraging an innovative molecular imaging platform we invented at
Stanford; multiplexed ion beam imaging (MIBI), in order to uncouple age- from cognitive decline-related cellular
senescence. MIBI enables us to quantify, with low nanometer resolution, high-dimensional, protein-level
expression patterns, single-cell (neuro/immune) interactions, and spatial localization of senescence- and AD-
relevant molecules (Aim 1) in a model of healthy aging (Aim 2) and well-characterized cases of AD related
cognitive impairment (Aim 3). Importantly, MIBI allows all of this to be accomplished in archival FFPE material,
thus allowing retrospective analysis on a variety of existing cohorts. By creating in-depth, phenotypic cellular
signatures with spatial context from our unique aging and cognitive cohorts, we will be able to provide insight
for modifiable factors promoting cognitive decline by filtering those specifically associated with aging alone. In
this research program, collaborative expertise in clinical neuropathology and cognitive decline, technological
advancements in imaging, biochemical/molecular and cellular biology, and machine learning analytics
converge in this proposed research program to address the spatio-cellular (neuro/immune, senescent)
heterogeneity in non-human primate (NHP) and human models of healthy aging and AD brains. Furthermore,
it will be synergistic to, and draw on expertise developed in existing infrastructure to image and organize AD
clinical pathology (R01AG056287, R01AG057915, MPIs: SC Bendall, RM Angelo, TJ Montine) as well as the
NIA-funded 90+ UCI cohort, control material housed in the Stanford ADRC, and NHP specimens (P50
AG047366 co-I: TJ Montine). We will reveal cellular senescent phenotypes that differentiate AD from normal
age-associated senescence.

Public health relevance
Project Narrative Alzheimer's disease (AD) is an age- and neurodegenerative related disease estimated to affect five million or more of the ageing American population by 2050. There is thus an urgent need to identify unique predictive signatures that correlate with developing AD. By using multi- parametric measurements with enabling technologies like multiplexed ion beam imaging (MIBI) we will be able to uncouple unhealthy brain senescence, that could be therapeutically targeted, from that associated with the normal aging process.